Examining distinct and shared mechanisms underlying arithmetic and reading development through behavioral and neural measures: alongitudinal investigation

SUMMARY
Arithmetic and reading are the most fundamental skills acquired during elementary school and are crucial for
successful academic achievement, employment prospects, and mental health. Despite the significance of
arithmetical and reading skills, many children and adults in developed societies exhibit deficient reading and
arithmetical abilities. Accumulating evidence suggests a strong neurocognitive and genetic link between reading
and arithmetic, with high co-occurrence rates of both reading and arithmetical learning difficulties. However, the
developmental trajectories of typical and atypical arithmetical and reading skills have been predominantly studied
apart and potential shared mechanisms of typical and atypical reading and arithmetic development are unknown.
This application proposes a longitudinal investigation that aims to (a) compare typical and atypical developmental
trajectories of reading and arithmetic from kindergarten to third grade, (b) characterize similarities, differences,
and classification power of neural and cognitive measures to profile the shared mechanisms underlying
arithmetic and reading, and (c) determine a set of predictors in kindergarten predicting arithmetic and reading
outcome after four years of formal instruction.
Employing a longitudinal study design, the proposed project aims to investigate the developmental relationships
of reading and arithmetic in the typical and atypical development of arithmetical skills from the beginning of
kindergarten to third grade, in 180 children with either a familial risk for arithmetic difficulties (AD), a familial risk
for reading difficulties (RD), or without any familial risk for reading or arithmetical difficulties, using functional and
structural brain measures and behavioral correlates. Neural correlates of arithmetic, reading, and related sub-
skills, together with a comprehensive psychometric battery measuring reading and arithmetical development and
domain-general and domain-specific skills, will be examined four times over four years during critical stages of
acquiring literacy and numerical concepts. By targeting children with a family history of AD and RD, and due to
the genetic profile overlap of these two conditions, the probability of children exhibiting atypical reading and
arithmetic development is increased, which will allow us to study and compare the developmental trajectories of
both typical and atypical reading and arithmetical skills.
This study has the potential to provide a model for understanding developmental learning disabilities, their
underlying mechanisms, and their co-occurrence. The current focus on a reactive, deficit-driven instead of a
preventive model in the field of learning disabilities is detrimental for students, as interventions have been proven
to be most effective at an earlier age of heightened brain plasticity and because of the implications for mental
health in struggling students as a result of a “wait-to-fail” approach. Understanding the shared and distinct
underlying cognitive and neural mechanisms between typical and atypical arithmetic and reading skills and their
precursors are of great significance for the development of early screening, diagnostic, and intervention tools.

Public health relevance
NARRATIVE Arithmetic and reading are the most fundamental skills acquired during elementary school, but despite their significance for academic achievement, employment prospects, and mental health, many children and adults in developed societies exhibit non-proficient reading and arithmetical abilities. A strong neurocognitive and genetic link between reading and arithmetic ability as well as high co-occurrence rates of reading and arithmetical learning difficulties have been shown, and this application proposes a longitudinal investigation that aims to (a) compare typical and atypical developmental trajectories of reading and arithmetic from kindergarten to third grade, (b) characterize similarities, differences, and classification power of neural and cognitive measures to profile the shared mechanisms underlying arithmetic and reading, and (c) determine a set of predictors in kindergarten of arithmetic and reading outcome after four years of formal instruction. Understanding the shared and distinct underlying neural and cognitive mechanisms between typical and atypical arithmetic and reading skills will be of great significance for the development of early screening, diagnostic, and intervention tools.